2022 Biology of Acute Respiratory Infection GRC / GRS

Project Summary
Despite the public health impact of acute respiratory infections, which has been made even more apparent by
the COVID-19 pandemic, recent and upcoming conferences focused on lung infections (of any kind) are
remarkably scant. This Gordon Research Conference (GRC) titled Biology of Acute Respiratory Infection seeks
to bridge multiple, diverse disciplines around this focal point with the goal of inciting novel translational
approaches to disease. This conference is designed to facilitate interaction and collaboration between
microbiologists, immunologists, pulmonologists, infectious disease physicians, veterinarians, epidemiologists,
public health officials, and others in related biomedical fields and at different stages of their career, who do not
usually attend the same meetings. Important in the design of the conference is the integration of basic and
applied scientists from academia, industry and the government from around the world. The GRC is preceded
by the Gordon Research Seminar (GRS), a unique forum for trainees and early career scientists with
comparable levels of experience to present and exchange new data and cutting-edge ideas. The primary goals
of the GRC/GRS Acute Biology of Respiratory Infections are to 1) to promote an interdisciplinary, coordinated
approach to understanding and controlling acute respiratory infections by integrating the scientific input from
clinicians, public health, and basic scientists; 2) To afford junior scientists multiple opportunities to present their
work to leading world experts; 3) provide a forum to facilitate collaborations. A secondary goal is to provide
training and career development opportunities for both new faculty and trainees at the associated GRS and
throughout the meeting. Interwoven in this goal is opportunity for women and others from underrepresented
groups to interact and develop relationships (e.g., mentors) with successful scientists from these same groups.
These goals will be accomplished by organizing a format where basic scientists meet and interact with
physicians, public health officials, scientists from industry and the government. The speaking program will
include a diverse mixture of invited Senior and Junior Scientists as well as speakers selected from submitted
abstracts. In addition, there will be poster sessions where all attendees will be encouraged to present. The
venue and program are designed to encourage social interaction and discussion outside of presentations to
provide the opportunity for fruitful exchange of ideas and to enable development of collaborations and future
training opportunities. The GRC Power Hour™ remains an integral part of the conference and is designed to
address challenges women and others from underrepresented groups face in science and issues of diversity
and inclusion. It is an open forum for discussion and mentoring in a safe environment that is open to all
attendees. This meeting provides the single-most comprehensive venue for discussing the latest advances in
pneumonia biology. We have chosen presentations specifically to increase the likelihood that attendees think
differently and more creatively about their research endeavors.

Public health relevance
Project Narrative Respiratory infections represent a worldwide public health crisis, which has been even further highlighted by the COVID-19 pandemic. The goal of the Gordon Research Conference (GRC) on the Biology of Acute Respiratory Infection is to assemble a multidisciplinary group of researchers committed to identifying novel biological paradigms controlling pneumonia outcome and susceptibility. This venue will uniquely coalesce individuals with a wide range of expertise (including basic science, clinical medicine, public health, and more), who would not normally attend the same conferences, providing unparalleled opportunities for highlighting innovative research in this area.